Understanding mechanisms of liver carcinogenesis following developmental BPA exposure

PROJECT SUMMARY
Exposure to the endocrine disrupting compound bisphenol A (BPA) is strongly correlated with risk for metabolic
syndrome (MetS) but mechanistic evidence is limited. MetS is defined by the co-occurrence of several correlated
cardiovascular disease risk factors, including insulin resistance and high blood triglycerides. MetS is a predictor
of type II diabetes, fatty liver disease, cardiovascular disease, and hepatocellular carcinoma (HCC); therefore,
preventing MetS reduces the burden of multiple diseases. Both MetS and BPA exposure are widespread
problems in the U.S. The national prevalence of MetS is 41% and rising; ~92% of the U.S. population are
chronically exposed to BPA. Thus, identifying a causal relationship between exposure and disease development
is crucial to improve prevention and treatment of MetS. The etiology of MetS is unknown, but current evidence
supports lipid accumulation followed by tissue-specific insulin resistance as initiating events. In liver, lipid
accumulation is promoted by persistent Nrf2 signaling and is prevented by estrogen receptor 1 (ESR1) signaling.
When cellular reactive oxygen species (ROS) is high, Nrf2 activates the transcription of antioxidant defense
enzymes and the sterol regulatory element-binding proteins (SREBPs), including SREBPF1, which encodes
SREBP-1c, which, in turn, triggers de novo lipogenesis. Persistent Srebp-1c upregulation leads to harmful
hepatic lipid deposition and downstream hepatic insulin resistance. BPA promotes ROS; therefore, we
hypothesize that BPA promotes MetS by increasing ROS and subsequently upregulating Srebp-1c. In contrast,
ESR1 signaling suppresses Srebp-1c expression and protects against hepatic lipid deposition and insulin
resistance, particularly in females. BPA is a weak ESR1 agonist that binds the receptor when endogenous
estrogen is low (e.g., in pre-pubertal females), but is incapable of eliciting transcription of ESR1 target genes.
We hypothesize that developmental BPA reverses this estrogenic protection. Therefore, our central hypothesis
is that developmental BPA exposure causes hepatic lipid deposition and insulin resistance by triggering
persistent, ROS-mediated Nrf2 signaling and by disrupting protective ESR1 signaling. In Aim 1, we will test the
causal role of cellular ROS in liver metabolic dysfunction by exposing to BPA mice that are genetically susceptible
to ROS-dependent metabolic syndrome (which should exacerbate metabolic dysfunction) and by co-exposing
mice to BPA and an antioxidant (which should rescue metabolic dysfunction). In Aim 2, we will test the causal
role of ESR1 signaling in liver metabolic dysfunction by experimentally increasing signaling (by co-exposing mice
to BPA and an ESR1 agonist) and decreasing signaling (by co-exposing mice to BPA and an ESR1 antagonist).
The results of these studies will clarify mechanisms by which this ubiquitous environmental pollutant explains
the substantial and increasing metabolic disease burden in the U.S.

Public health relevance
PROJECT NARRATIVE Bisphenol A (BPA) is a ubiquitous, endocrine disrupting compound with known associations with metabolic dysfunction, however, the mechanism(s) underlying this link are largely unknown. Our research will test two related but independent mechanisms underlying hepatic lipid deposition and insulin resistance in mice exposed to BPA during development. This work will shed critical light on mechanisms underlying the metabolic disruption potential of BPA, which will directly inform both epidemiological study design and human health risks due to BPA exposure.